Warm sensitive neurons that control body temperature

? DESCRIPTION (provided by applicant): A better understanding of the mammalian thermoregulatory system may lead to new therapeutic strategies for the treatment of conditions associated with hyperthermia such as infection, drug abuse, and stroke. Classical studies identified the preoptic area (POA) of the anterior hypothalamus as the principal site of mammalian thermoregulation. This region is postulated to contain warm-sensitive neurons that are activated by environmental heat and in response trigger an array of autonomic and behavioral responses that restore temperature homeostasis. An extensive scientific literature accumulated over the past 75 years has supported the existence and importance of these warm-sensitive cells, yet their neurochemical identity remains unknown. For this reason key components of the mammalian thermoregulatory circuit have remained inaccessible to modern genetically-targeted approaches in neuroscience. Recently we have used an approach for activity- based RNA sequencing to identify molecular markers that selectively label these long-sought warm-sensitive cells. We have shown using cell-type-specific optogenetic manipulations that activation of these neurons inhibits brown adipose tissue thermogenesis and lowers body temperature. We have also recorded the activity of these neurons in awake behaving mice and shown that they are activated by ambient heat and inhibited by ambient cold. Thus we have identified a novel, molecularly-defined neural population that functionally resembles the long-sought warm-sensitive cells of the POA. We propose here to apply approaches for genetic and projection-targeted neural manipulation and recording to elucidate the downstream circuit by which these cells control behavioral and autonomic thermoregulation.

Public health relevance
PUBLIC HEALTH RELEVANCE Narrative Body temperature is controlled by neural circuits in the brain that remain poorly understood. A better understanding of the structure and dynamics of these circuits would advance our ability to develop new therapeutic approaches for the treatment of medical conditions associated with hyperthermia such as stroke, infection and drug abuse. This proposal utilizes state-of-the-art approaches to selectively manipulate and record the activity of the key neurons that control body temperature in mammals.